Admin Supplement-Renovating Housing Enclosures at the Caribbean Primate Research Center

Project abstract: The Caribbean Primate Research Center (CPRC) is a research, training and educational unit of the University of Puerto Rico (UPR) Medical Sciences Campus. Since 1938, the Center has supplied the scientific community with Indian origin rhesus macaques with known backgrounds and of the same genetic pool for use in studies of basic biology and disease (HIV, WNV, Dengue, Zika and others). The CPRC has vast experience in the establishment and maintenance of rhesus macaque (M. mulatta) breeding colonies. The animal care and use program of the CPRC is in compliance with the directives established by the Animal Welfare Act (AWA), PHS and other agencies. The CPRC is AAALAC accredited. Macaques are supported by a P40, a U42 grant, Institutional funds, and are made available to the scientific community for biomedical research. Part of the housing infrastructure of the Center's - Sabana Seca Field Station (SSFS) colony supported by the parent P40 grant, is suffering of a significant deterioration. Thus, the major goal of this administrative supplement application is to improve part of the CPRC's housing condition according to the parent grant objectives.

Public health relevance
Project Narrative The major goal of this administrative supplement application for the Parent Grant P40 of the he Caribbean Primate Research Center's (CPRC) is to renovate and improve part of the housing capabilities at the Sabana Seca Field Station. The CPRC consists of two (2) intefrated animal facilities (1) Cayo Santiago, a unique research resources that holds a colony of free-ranging rhesus descendant of a group of animals brought from India to Cayo Santiago (CS) in 1938; (2) the Sabana Seca Field Station , the CPRC's head quarters located 10 miles outside of San Juan that houses rhesus monkeys derived from Cayo Santiago colony in various outdoor configurations for biomedical and behavioral studies that are not feasible on free-ranging animals; For more than 40 years, the SSFS, had established a solid program that supports numerous PHS-sponsored research. The Center provides unadmixed indian-origin rhesus monkeys with defined genetic and virological background that serve as models for the development of effective diseases treatments and vaccine. The CPRC will continue to be one of the largest nation-wide provider of rhesus monkeys for biomedical research projects, as well as a valuable research resource needed for biomedical studies. Funds are requested in this application to renovate part of the housing infrastructure of the SSFS colony which is suffering of a significant deterioration. Also, the renovation can provide space for the animals that are annually removed from Cayo Santiago for population control. .